2024 Microbial Toxins and Pathogenicity Gordon Research Conference and Seminar

Project Summary
The 2024 Microbial Toxins and Pathogenicity Gordon Research Conference (GRC) and its accompanying
Gordon Research Seminar (GRS) “Microbes, Metabolism, Microbiome, Toxins and Disease” are designed to
showcase exciting, innovative basic and applied research in the infectious disease field while promoting
thoughtful discussion and networking between new and veteran researchers from the academic, biotech and
government sectors. Since its inception in 1972, this biennial international conference continues to be
regarded by the microbial pathogenesis community as our premier venue for intellectual exchange. To be held
July 14-19 at Waterville Valley Conference Center in New Hampshire, the 2024 Conference is led by Chair
Mary X.D. O’Riordan, PhD, Professor in the Department of Microbiology & Immunology at the University of
Michigan, and Vice Chair Victor J. Torres, PhD, Professor & Chair of the Department of Host-Microbe
Interactions at St. Jude’s Medical Center. Nine sessions will feature 32 invited speakers (plus 4 from the GRS),
chosen to integrate cutting- edge research on: bacterial toxins and physiology, new approaches to study
pathogens in the molecular, cellular and meta-organism contexts of the host including the associated
microbiome, and how pathogens engage and evade host innate immune responses. To highlight the
accomplishments of the next generation of scientists in our field, the GRC will be preceded by a GRS – a
unique forum planned, led and attended by pre- and post- doctoral trainees. The 2024 Gordon Research
Seminar Co-Chairs are Valeria Reyes Ruiz, Postdoctoral Fellow, Vanderbilt University Medical Center and
Sean Callahan, Postdoctoral Fellow, University of Pennsylvania Perelman School of Medicine. The primary
goals of the Microbial Toxins & Pathogenicity GRC/GRS are 1) to promote interdisciplinary interactions
between scientists studying different facets of infectious disease; 2) to afford early career scientists
opportunities to present their work to disciplinary experts; 3) provide a forum to stimulate ideas and
collaborations, and 4) to provide training and career development opportunities for both new faculty and
trainees. An intentional and anticipated outcome of the conference is for scientists from historically
marginalized groups to have the opportunity to interact and develop professional mentoring relationships with
successful scientists with similar lived experiences. The GRC Power HourTM remains an integral part of the
conference and is designed to address challenges women and others from underrepresented groups face in
science. Afternoon poster sessions will promote extended scientific discussions and networking between
colleagues within and across disciplines and ranks. Together the Seminar and Conference promise to provide
an exceptional and inclusive forum for a diverse community of scientists to learn about exciting discoveries in
the field, and consider and challenge the current paradigms, barriers and opportunities to advancing
knowledge of molecular mechanisms of microbial pathogenesis.

Public health relevance
Project Narrative The 2024 Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) on Microbial Toxins and Pathogenicity are the premiere events that showcase exciting, innovative basic and applied research in the field of infectious disease. The GRC and GRS promote open discussions and active networking between new and veteran researchers from academia and government, medicine and biotech. In addition to providing an exceptional forum for a diverse community of scientists to learn and discuss the latest discoveries in the field, the GRC and GRS provide exceptional opportunities for the professional development of the next generation of researchers and promotes their success within the broader scientific community.